Transit-Oriented Development: Implications for Childhood Obesity and Asthma

Project Summary / Abstract
The US is in the midst of a housing affordability crisis, which fuels health inequities for children in low-income
families including high rates of obesity and asthma exacerbations. To combat housing crisis, cities across the
United States have turned to transit-oriented development, a type of urban planning that incentivizes developers
to build dense, affordable housing in urban cores, near jobs and public transit. Transit-oriented development
could improve obesity and asthma outcomes for low-income children by expanding access to affordable housing,
transit, and healthy neighborhoods. Despite this promise, few studies have rigorously evaluated the impact of
transit-oriented development on children's health outcomes. Los Angeles, California's Transit-Oriented
Communities (TOC) program, which has led to the production of nearly 10,000 affordable housing units, offers
an opportunity to study health implications of transit-oriented development. Our project will leverage TOC as a
natural experiment, comparing change in obesity and asthma over time among children in neighborhoods eligible
vs. ineligible for TOC (Aim 1). Secondary outcomes for Aim 1 include caregiver mental health and child physical
activity. Second, we will explore potential mechanisms underlying Aim 1 associations, by measuring TOC's
impact on more proximal outcomes, including housing affordability, transit use, and neighborhood environments
(Aim 2). Finally, we will conduct qualitative interviews with caregivers living in TOCs as well as TOC developers
and policymakers to contextualize quantitative findings and better understand peoples' lived experience with the
program (Aim 3). Together, these aims will allow us to retrospectively measure TOC's impact on wellbeing, while
also identifying opportunities to change the program to better promote health going forward. Results will be
relevant to decisionmakers in Los Angeles and peer cities pursuing transit-oriented development.
Research proposed under this K01 award will support Dr. Leifheit's mentored career development by providing
opportunities for practical application of her training goals. Specifically, she will receive training in: (1) child
obesity and asthma epidemiology, (2) geospatial analysis, (3) qualitative research, and (4) policy translation. A
team of expert mentors will oversee Dr. Leifheit's training in these methods, content areas, and overall career
development. This award will launch Dr. Leifheit's career as an independent investigator, providing her with the
skills to collect mixed-methods data on child health implications of urban planning decisions. The project will also
yield valuable preliminary data for future, R01-funded research measuring TOC's impact on children's
longitudinal health trajectories.

Public health relevance
Project Narrative To address the US housing affordability crisis, cities across the country are incentivizing the construction of affordable housing along mass transit. Using mixed-methods data from Los Angeles, California, we will measure one such initiative’s impact on obesity and asthma in children, exploring mechanisms related to housing affordability, transit use, and neighborhood environments. With training in child obesity and asthma epidemiology, geospatial analysis, qualitative research, and policy translation, I will produce results that help tailor urban planning policies to promote positive child health outcomes.